Implications of state alcohol policy for college students' binge drinking, suicidal behavior, and sexual assault victimization

Project Summary/Abstract
The proposed research examines the extent to which more restrictive state alcohol policy environments are
associated with binge drinking in diverse subgroups of young adult college students, and with two alcohol use-
related outcomes: suicidal behavior and sexual assault victimization. This research will be accomplished using
repeated cross-sectional National College Health Assessment (NCHA) data. NCHA was administered twice
yearly from 2008-2019 to an estimated 921,000 18-24 year old undergraduates from more than 500 four-year
colleges in 48 states. NCHA data will be merged with time- and state-specific data on alcohol policy and state
population estimates of per capita alcohol use and binge drinking. The primary predictor is the Alcohol Policy
Scale (APS), a state-specific time-varying measure based on 29 policies, weighted by efficacy and degree of
implementation, with subscales grouped by policy domain and mechanism. Analyses will account for individual
and institutional covariates and clustering of respondents within institutions within states. In Aim 1 we will
specify the extent to which alcohol policy restrictiveness and state population drinking measures predict
college students’ binge drinking. A focus will be identifying differences in policy effects by students’
race/ethnicity, sex, age (minors vs. age ≥ 21), and sexual orientation. In Aim 2 we will estimate the statistical
effects of more restrictive alcohol policies on suicidal ideation, self-harm, and suicide attempt via (mediated by)
binge drinking. For Aim 3 we will quantify associations between more restrictive state alcohol policy
environments and respondents’ sexual victimization, which we hypothesize will be only partially mediated by
respondents’ binge drinking. Partial mediation is expected given the potential for alcohol policies to affect
campus and community drinking contexts and alcohol use by perpetrators and bystanders. Identifying how
alcohol policy relates to binge drinking in understudied subgroups and to young adults’ suicide and sexual
assault risk is consistent with NIAAA’s Strategic Plan Goal 3 to improve strategies to prevent alcohol misuse
and alcohol-related consequences. Findings on state-level protective contexts will inform planning and
prioritization of distal and proximal (e.g., individually-oriented) prevention at national, state, and campus levels.

Public health relevance
Project Narrative This proposed research will quantify the associations that more restrictive state alcohol policy environments have with binge drinking among young adult college students overall, and within subgroups that experience disparities. The project then specifies relations that state alcohol policies have with suicide and sexual assault risk, through effects on binge drinking. Accounting for the distal protective effects of state alcohol policies will inform other state- and campus-level planning to prevent alcohol misuse, suicide, and sexual assault, consistent with NIAAA Strategic Plan Goal 3.